R-METHU GLIAL NEUROTROPHIC FACTOR IN IDIOPATHIC PARKINSONS DISEASE

Randomized Double-Blind, Placebo-Controlled, Dose-Escalation Trial of Intracerebroventricular Recombinant-Methionyl Human Glial Cell Line- Derived Neurotrophic Factor (r-metHuGDNF) for the treatment of Patients with Idiopathic Parkinsons Diease.